Omics for TB: Response to Infection and Treatment

Abstract – Overview
With about 10 million new cases of active disease and 1.8 million deaths annually, TB is a global health
emergency. A distinguishing feature of TB disease is its biological heterogeneity, which manifests at the clinical
level chiefly in 2 forms: disease progression and treatment response. The premise of this Program is that the
heterogeneous outcomes of TB infection and treatment are determined by the interplay of competing
regulatory networks between the pathogen and the host. Our primary goal is to apply systems biology
approaches to elucidate the biological control underlying the variability of disease outcome and response to
treatment. Our first specific aim is to define novel host regulators of TB disease progression in vivo, and the
innate and adaptive networks they control. We will also seek to define novel Mtb regulators of TB treatment
response, and the Mtb regulatory networks that they control. This work will allow us to produce and validate
host and Mtb models of TB disease progression and treatment response. Altogether, this program addresses
key unanswered questions that stymie efforts to combat the TB pandemic. Our team has perfected the
required platforms and scientific approaches to execute this ambitious research plan in a timely and cost-
effective manner. All the participating investigators have strong records of interacting productively, and of
disseminating their data and reagents to the scientific community.

Public health relevance
Project Narrative - Omics for TB: Response to Infection and Treatment Mycobacterium tuberculosis causes ~10 million new cases of active disease and 1.8 million deaths each year, and our tools to combat tuberculosis (TB) disease are universally outdated and overmatched. This project combines separate advances in systems biology and network modeling to produce experimentally grounded and verifiable systems-level models of the host and MTB regulatory networks that affect disease progression and response to treatment.